Integrated Supportive Care Policies to Improve Maternal Health Equity: Evaluating the Multi-level Effects and Implementation of Doula Programs for Medicaid-Eligible Birthing People in New York City

In New York City (NYC) and State (NYS), pervasive inequalities in access to respectful, culturally congruent,
patient-centered maternity services drive maternal mortality (MM) rates that are 8× higher for Black versus
White individuals and severe maternal mortality (SMM) rates that are 2.3× higher. Policy interventions that
emphasize Medicaid, which serves low-income and racially and ethnically minoritized populations at greatest
risk of SMM/MM, and that increase access to quality obstetric services and improve the social and structural
determinants of health (SDOH) - i.e., integrated supportive care (ISC) - hold significant promise. NYC and NYS
are at the forefront of Medicaid-relevant doula programs, with recent policy advances to expand the Maternity
Hospital Quality Improvement Network (MHQIN), which supports hospitals in integrating doulas, Standards for
Respectful Care, implicit bias trainings, SDOH clinical reviews, and community linkages into care structures,
and the Citywide Doula Initiative (CDI), which trains and provides doulas at no cost for NYC residents in select
neighborhoods who are income-eligible for Medicaid. However, there is little empirical evidence on the
effectiveness of doula care models or the facilitators and barriers doulas face in practicing within their full
scope, integrating into the care team, and strategies for effective, sustainable ISC policy implementation, in
part because state Medicaid programs have not included doula services and the community and governmental
organizations delivering them have limited research capacity. Guided by our multi-sector partnership and novel
integrated conceptual framework, we propose a rigorous mixed-methods evaluation of the multi-level impacts
and implementation of NYC’s doula programs. In Aim 1, we will use a quasi-experimental design and unique
Medicaid claims linked to social services data to evaluate the overall and differential effects by race, ethnicity,
age, socioeconomic status, and geography of the CDI on 1a) birth, mental health, cardiovascular, and SMM
outcomes; 1b) prenatal and postpartum healthcare utilization; and 1c) receipt of social services, among
Medicaid-eligible birthing people from 2022 to 2027. In Aim 2, we will analyze diverse perspectives on and
experiences with the MHQIN program components and its implementation among birthing clients and hospital,
Medicaid, and doulas/community stakeholders via in-depth individual interviews, focus group discussions, and
surveys. In Aim 3, our Community Coalition Research Leadership Advisory Board will lead a co-design process
to develop an evidence-based strategic plan for policy implementation to scale and sustain Medicaid-supported
ISC, including doula reimbursement. We will generate new evidence on the role that doulas play in improving
maternal health equity, strengthen local partnerships for policy action, and serve as a model for national
replicability. Our proposal is highly aligned with NIH’s strategic plan for innovative research to advance
community-derived, multi-level policy solutions to redress the crisis of MM for birthing people across the U.S.

Public health relevance
Policy solutions that center the needs, priorities, and assets of birthing people and communities are required to address the stark and longstanding social disparities in pregnancy-related deaths and disability in New York City (NYC) and elsewhere. Integrated supportive care models (ISC) that increase access to quality obstetric services and improve the social determinants of health hold significant promise but are lacking empirical evidence. Guided by our academic-governmental-community partnership, our mixed-methods project will provide critical, timely new information on the multi-level impacts and implementation of NYC’s Medicaid- supported doula programs to inform dissemination and sustainability of policy-relevant ISC interventions and improve maternal health and health equity for birthing people in the United States.